Long-read DNA sequencing of Parkinson's disease and related disorders

Parkinsons disease is a major neurodegenerative disease. Genetics clearly plays a role in disease. Our aim for the long-read DNA sequencing of Parkinson's disease and related disorders project is to identify novel causal and risk DNA mutations for Parkinson's disease. By using DNA isolated from brains or blood from subjects diagnosed with Parkinson's disease and control subjects we aim to generate long-read DNA sequencing data. These data will be integrated with existing short read data and analyzed to identify genomic structural variants with large scale changes or repeat expansions and to evaluate the epigenetic landscape and genetic architecture of challenging regions. All raw and processed sequence data will be made publicly available to the scientific community.